Defining Optimal Radiotherapy Dose and Fractionation in Combination with Preoperative Immuno-Chemotherapy in Early-Stage Triple Negative Breast Cancer

SUMMARY
Our goal is to develop a novel approach to rationally incorporate radiotherapy (RT) to improve the outcome of
neoadjuvant therapy in patients with lymph node positive, triple-negative breast cancer (TNBC). The mature
results from the KEYNOTE-522 trial, which tested the addition of immune checkpoint inhibitor (ICI),
pembrolizumab, to neoadjuvant chemotherapy (NAC), defined the new standard of care in early-stage TNBC,
based on improved pathologic complete response rates and event-free survival. Despite this breakthrough,
approximately 35% of patients will not respond to pembrolizumab and NAC. These “non-responders” represent
patients with biologically aggressive, immunotherapy-resistant TNBC, for whom novel strategies to overcome
immunotherapy resistance are desperately needed. While pilot studies have demonstrated the combination of
RT with pembrolizumab to be safe and showed early signals of efficacy in TNBC (NCT02730130,
NCT03366844), the optimal dose of RT to be combined with the new standard pembrolizomab/NAC regimen
remains undefined, impeding progress in designing larger clinical trials to test this compelling approach. We will
generate this knowledge through expanding our ongoing clinical trial, P-RAD: A Randomized Study of
Preoperative Chemotherapy, Pembrolizumab and No, Low or High Dose RADiation in Node-Positive, HER2–
Cancer; NCT04443348). Our multidisciplinary team will define the optimal dose of RT to combine with
pembrolizumab by testing the different doses of RT (0Gy, 9Gy and 24Gy) with neoadjuvant pembrolizumab/NAC
in early-stage TNBC patients. The study is designed to also bridge the knowledge gap in terms of the effects of
RT on immune responses in the context of combination with immuno-chemotherapy in TNBC. This will be
achieved through immunoprofiling studies of serial TNBC tissue and blood samples in correlative studies. We
propose comprehensive studies of the interplay between RT and pembrolizumab/NAC to reveal differences
between responders and non-responders to this combined local and novel systemic therapy in early-stage
TNBC. We expect to show that reprogramming the immune microenvironment of TNBC will result in greater
benefit for immunotherapy and may help select patients that may optimally benefit from the addition of RT to
pembrolizumab/NAC. Based on enticing hypotheses and compelling preliminary data, availability tissue
specimens and patients from geographic TNBC catchment areas and industry support, we propose the two
integrated aims: 1) To establish the effect of RT boost dose (0Gy, 9Gy or 24Gy) delivered to the primary breast
tumor in combination with pembrolizumab followed by standard-of-care pembrolizumab/NAC on pathologic
complete response (pCR) rates in node-positive TNBC patients, and; 2) To define the dose-dependent effects
of RT with pembrolizumab/NAC on the TNBC immune microenvironment and systemic immunity. Successful
completion of this study will directly inform the testing of this approach in a large, phase III randomized trial and
will contribute to a paradigm shift by transforming the role of preoperative RT in the new era of
immunochemotherapy in TNBC.

Public health relevance
NARRATIVE Defining a forward path for successful implementation of preoperative radiotherapy boost to enhance the efficacy of standard neoadjuvant immunotherapy-chemotherapy in early-stage triple negative breast cancer represents a novel and potentially groundbreaking treatment paradigm. This randomized phase II study, P-RAD: A Randomized Trial of Preoperative Pembrolizumab with No, Low or High Dose RADiation Therapy in HER2- Negative Breast Cancer, will define the optimal RT dose (0Gy, 9Gy or 24Gy) for the radiotherapy boost to combine with immune checkpoint inhibitor and chemotherapy. In addition to the co-primary endpoints of pathologic complete response rate and change in tumor-infiltrating lymphocytes, the study will provide unique insights through a comprehensive assessment of serial tumor tissue and blood samples in correlative studies.